Interpretable Deep Learning Models for Analysis of Longitudinal 3D Mammography Screenings

Project Summary
Mammography screening for breast cancer has clear, substantial benefits, including significantly reduced breast
cancer mortality and improved treatment options for early detected cancers. However, regular mammography
screenings subject women to several potential harms, including high false positive rates, with over 60% of women
experiencing a false positive finding after 10 years of annual screening; high false negative rates, with more can-
cers missed in dense breasts which obscure tumor appearance; and high recall rates, causing undue anxiety
and unnecessary, potentially invasive workup for women with a false positive screen. New 3D mammography
technology called digital breast tomosynthesis (DBT) has shown increased cancer detection and decreased re-
call rates, but radiologists require longer interpretation time and may lack experience. The clinical workflow could
potentially be enhanced with computer aided detection systems. However, current methods only focus on a single
mammogram exam, ignoring crucial decision-making information that a radiologist would consider, such as prior
mammograms, patient demographics, and personal history. Conversely, established breast cancer risk models
rely only on patient demographics and personal/family history, excluding mammographic history. Toward the
overarching goal of reducing the harms and increasing the benefits of mammography screening, we propose to
increase accuracy of breast cancer detection and predict future cancer development from serial 3D mammogram
screenings using a novel deep learning model that jointly incorporates spatial, temporal, and non-imaging clinical
information. Our method adopts attention-based neural networks, i.e., Transformers, which learn complex depen-
dencies between different elements in a sequence and automatically attend to the most relevant information. In
addition to the potential for improved performance, the attention mechanism provides built-in model interpretation
to better understand the inputs that are important for the model’s predictions, instilling user confidence in the
model and facilitating extraction of mammographic biomarkers for breast cancer detection and development. Our
specific aims are to: 1) develop a powerful deep learning model for simultaneously leveraging spatial, temporal,
and non-imaging clinical information from DBT exams; 2) create a new tool to detect breast cancer from lon-
gitudinal DBT screenings; and 3) develop a new model for predicting development of breast cancer based on
longitudinal DBT studies and extract 3D mammographic biomarkers associated with cancer development. Be-
yond the direct benefit of improved breast cancer detection and risk estimation, this work could reduce radiologist
reading time and workload, inform new individualized screening protocols, further our understanding of the role
of breast architecture in cancer risk, and guide development and monitoring of preventive treatments. Finally,
the developed deep learning methodology will have wide applicability to spatiotemporal analysis in other medical
conditions and imaging domains.

Public health relevance
Project Narrative Routine mammography screening for early cancer detection has significantly reduced breast cancer mortality, but also subjects women to several potential harms, including incorrect results and unnecessary recall with po- tentially invasive procedures. The goal of this project is to increase accuracy of breast cancer detection and risk estimation through the development of new deep learning models that consider a patient’s mammogram screening history. This work would improve breast cancer detection, inform individualized screening protocols, and guide development and monitoring of tissue-modifying preventive cancer treatments.